Aging-related mitochondrial degeneration and degenerative diseases

DESCRIPTION (provided by applicant): Mitochondrial function degenerates with aging. The overall goals of our proposal are (1) to better understand how aging induces mitochondrial degeneration and (2) to identify cellular pathways other than the currently known anti-oxidative mechanisms that can potentially delay the degenerative process. In the previous grant period, we developed a yeast model for the adult/late-onset neuromuscular degenerative disease autosomal dominant Progressive External Ophthalmoplegia (adPEO), caused by gain-of-function mutations in the adenine nucleotide translocase (Ant). Ant is normally involved in ADP/ATP exchange across the mitochondrial inner membrane. We found that equivalent mutations in yeast induce aging-dependent mitochondrial depolarization and -aging prohibitin mutants. These unique experimental systems enabled us to unequivocally demonstrate that reducing cytosolic protein synthesis can robustly suppress aging-dependent mitochondrial degeneration. This finding reveals an unanticipated link between cellular protein homeostasis (or proteostasis) and the functional integrity of mitochondria. In a recent genetic screen for anti-degenerative suppressors, we identified genes involved in cytosolic mRNA decay and protein degradation. Several of these proteostatic genes/pathways have human orthologs known to be mutated in degenerative diseases. These observations led to our central hypothesis that loss of protein homeostasis in the cytosol may induce proteostatic stress on the mitochondrial inner membrane, which consequently affects energy homeostasis and the fitness of aged cells. To test this, we propose the following aims: (1) We will examine the link between cellular proteostasis and mitochondrial integrity during replicative aging. We will specifically determine whether defects in mRNA decay and protein degradation, which cause protein phenotypically tractable degenerative cell death. These phenotypes were also independently captured in the pro overloading from the cytosol, can generally accelerate aging-dependent mitochondrial degeneration; (2) We will test the hypothesis that cytosolic proteostatic stress may affect protein homeostasis, respiratory complex biogenesis, bioenergetic efficiency and structural integrity of the mitochondrial inner membrane; and (3) By taking advantage of the anti-degenerative genes identified in our study, we will examine whether over-expression of these genes, which improves mitochondrial membrane integrity and energy transduction, extends cell's lifespan. Because decline of cellular proteostasis is a common molecular symptom of aging and some degenerative diseases, our studies may help us better understand the mechanism of mitochondrial degeneration under these conditions.

Public health relevance
The mitochondrion is known as the powerhouse of the cell and its function degenerates with aging and in aging-related degenerative disorders. We aim to identify evolutionarily conserved cellular pathways that can delay the aging-dependent degeneration of mitochondria and improve energy homeostasis in aged cells. These "anti-degenerative" pathways may be potentially used as intervention targets for delaying the onset and progression of mitochondrial degeneration.